University of Minnesota Clinical and Translational Science Institute (UMN CTSI)

Abstract. Clinical and translational science (CTS) is at the crossroads of major technology advances requiring
academia-community partnerships anchored on trust for effective & rapid deployment of best practices. UMN
CTSA Hub will build on proven commitments to accelerate impactful CTS. Aim 1 will provide novel
infrastructure to reduce research barriers and accelerate translation to practice via a new Office of Clinical
Research and Community Affairs to augment CTSI’s capacity to respond to and facilitate robust and
sustainable community relationships transcending single investigator projects. Aim 2 will deliver high quality
and efficient research services and resources via Clinical Research Support Center (85 staff) that will lessen
trial barriers and support all aspects of study design, biostatistics, bioinformatics, regulatory compliance,
contracts and more. Accelerating diversity, equity and inclusion progress will facilitate connectivity to our
diverse population. A learning health system (LHS) and continuous quality improvement program will expedite
implementation of novel enhancements. Aim 3 will cultivate and train a strong, diverse CTS workforce with
new tools and programs; develop and test novel trial processes and participant satisfaction; then disseminate
and implement learnings locally and nationally. Tailored enhancements will personalize CTS training for
community, academic and workforce professionals, with attention to diversity, informed consent for non-
English speakers, an investigator primer, research career development series and more. CTSI’s Rural Health
Program offers an Equity Postdoctoral Fellowship and year-long community leader training in health policy &
leadership. Cultural competency training will facilitate engagement with our multicultural community. Trained
community health workers (CHWs) will advance research dissemination into practice and community. Aim 4
will foster leadership, team science and data sharing to support collaborations including leadership programs,
professional coaching, vertically integrated retreats, team function seminars, Northern Leadership for
Innovative Team Science program adapted for junior faculty and incentives to gain CTSI leadership skills.
Health Informatics will support advanced data management, analytic infrastructures plus electronic health
record & LHS information systems. Aim 5 strives for health equity and against structural racism by deploying
an Equity Framework and antiracist research practices to train CHWs and Hub Partners for broad community
input and decision-making. We will build a national population level geo-database of quantifiable measures of
cultural and economic variables using a novel Multidimentional Measures of Systemic Racism Portal to link
health and clinical data, define national impact of structural racism on study enrollment and data collection with
a validation project on early childhood cognitive function after prenatal methamphetamine exposure. Impact.
With a novel infrastructure, a diverse next generation of leaders and a well-trained diverse workforce, our Hub
and regional community will co-develop and implement CTS advancements to improve health.

Public health relevance
UMN CTSI UM1 Project Narrative The University of Minnesota's Clinical and Translational Science Institute, together with its Partners and Collaborators, will find better, faster ways to bring scientific advances to real-world use. To do this, we will reduce research barriers, provide high-quality services for researchers, foster and train a diverse research workforce, broadly share findings, build sustainable relationships with our Minnesota communities, and more. This work, combined with our focus on health equity and impact, ultimately aims to make healthcare better for everyone.